Administrative Core

The administrative core, Core A, will provide administrative and fiscal management for the projects and cores of the P01. The goals are to organize staff administer the projects and cores in conjunction with project leaders, core directors and institutional staff, organize and conduct monthly meetings of P01 participants and annual meetings of P01 participants and the Scientific Advisory Board (SAB), prepare the necessary documents related to P01 activities, including reports of P01 investigator meetings and the SAB, and prepare progress reports for official agencies, facilitate interaction between individual projects and between projects and cores and monitor the progress of the individual projects on a regular basis, to maintain appropriate fiscal oversight of the projects and cords and prepare necessary fiscal reports of official agencies, and to assure compliance with appropriate regulations regarding experimentation with human subjects including gender and minor participation an vertebrate animals. RELEVANCE (See instructions): Core A is necessary to organize and coordinate the projects and other cores.